Coordination Core

ABSTRACT: COORDINATION CORE
The coordination core has an administrative and scientific function. It will initiate the administrative
process of procuring the human skeletal tissues that will be used by the mineralized tissue project. Our
LIMS will be modified to capture all the workflow activities from the acquisition to handoff to the
mineralized tissue project group. This includes recording the orientation of the sample relative to the
tissue of origin, obtaining a µCT scan of the mineral distribution, embedding the tissue for serial
sectioning that incorporates four registration points that define a grid structure for cell localization. After
widefield histological images are recorded, the same sections are transferred to the mineralization core
for the seqFISH studies that identify cell type and individual cell RNA transcriptone profile. Using the
same grid system, a 3D cell map will be generated by the data analysis core which in turn will interact
with the coordination core to align the histological and 3D cell map. Together the two cores will build a
visual representation of the cells within a tissue block that interchangeably relate a specific cell with its
transcriptional profile and the active molecular pathways. In an iterative process that will be driven by
the coordination core, quality control standards for identification of cell types as well as subdivisions
within a cell type will be developed that will serve as the basis for imputing the activity of interacting
cells or comparing differences in regulation of cell behavior that underlie dimorphic differences based
on sex or ethnicity. As we become proficient in the technologies and data management process of cell
mapping, we will shape our data presentation format to that used by other members of the HIVE. By
direct interaction with other scientific groups in HuBMAP, we hope to expand the multimodal
interrogation of our skeletal tissues and contribute to the technological capabilities of other HuBMAP
members. The coordination core will also reach out to the skeletal biology community to make them
aware of the resources of the HIVE and provide workshops to help other major skeletal biology groups
implement this technology in their research environment. The technologies and concepts of HuBMAP
will be transformational for understanding normal and pathological processes in human disease. We
want to adapt this experimental platform to tissues of the mineralized skeleton and advocate for its
adoption throughout the skeletal research community.